ADMINISTRATION, BUDGETING, AND OPERATIONS

The Administrative Core will provide centralized grant administration, communication processing, and budget management. This Core is critical in order to amalgamate the efforts of the Project investigators, their experimental findings and their ideas, to evaluate research efforts and to direct the summary efforts toward the Program outcome. In addition, in conjunction with the Biostatistics and Data Management Core (Core B), Core A will create and operate a secure web site for the interchange of data, communications, and the evaluation of Program progress. Core A will also provide the programmatic infrastructure to integrate the special services of Cores C, D, & E with the projects, and efficiently manage these resources. The Specific Aims of the Administrative Core are to: 1. Provide basic administrative services to the investigators. [unreadable] This includes the management of project supplies, filing, development of memos, meeting minutes and communications covering all operations, including publications. By design, this core will provide investigators with clear lines of scientific and administrative communication to promote collaboration among team members, aid in the prioritization of resources, and facilitate resolution of any problems that affect team members. [unreadable] To install data prioritization evaluation and inter-institutional secure website for sharing and storing data bases. Provide access in real time to data sets and standardization of data sets to permit data managers from all institutions to have input on final statistics and direct modeling and experimental design over the program course. 2. Organize monthly meetings of the Program Steering Committee. [unreadable] This Steering committee shall consist of the Project and Core Pis. 3. Organize an annual Internal Advisor Review meeting where a panel of experts shall assess the Program effectiveness and experimental progress, research directions, technical approaches, statistical evaluation, and administrative effectiveness. 4. Organize an annual External Review Panel meeting. [unreadable] The members of External Review Panel shall review all experimental findings and clinical outcomes, help prioritize investigations, review the coordination of collaborations, and evaluate concepts that emerge from the studies. 5. Provide publication services to the investigators for project-related communications where this includes the preparation of manuscripts, abstracts, publications, data sharing, IP, protocols, corporate agreements, and compliance issues. 6. Provide overall fiscal review, accounting, and real time budget analyses. [unreadable] To conduct and direct the budget analysis including both descriptive summary expenditures and real- time tracking of individual budgets. [unreadable] Provide forward-looking projections on expenditures. These can be correlated with project progress to provide superior Program management. [unreadable] Provide timely review, quality assurance, and dissemination of the budgets in all projects.